The Shapes of Family Conflict: Differentiating Adaptive and Maladaptive Parent-Child Conflict in Daily Life

PROJECT SUMMARY
The overall goal of this application is to provide the principal investigator with targeted training in advanced
methods for capturing and analyzing daily family dynamics relevant to child mental health. In the long term,
the applicant intends to establish an independent research career focused on how everyday family processes
shape children’s development, with the goal of informing interventions that strengthen family functioning and
support mental health. To support this trajectory, the proposed training plan includes focused development in
three key areas: (1) interdisciplinary collaboration to integrate technology into the study of family interactions,
(2) advanced statistical methods for analyzing large, multimodal datasets, and (3) the conceptualization and
dissemination of findings on adaptive and maladaptive family processes in daily life. Together, these
components will lay the groundwork for a research career focused on advancing the science of family processes
and enhancing interventions that support child and family well-being.
Children’s exposure to family conflict can significantly shape their development, influencing both mental
health symptoms and how they manage conflict in the future. While some conflicts promote problem-solving
and emotional growth, others escalate into maladaptive patterns that increase the risk for mental health
symptoms. Yet, key questions remain about the core features that distinguish adaptive from maladaptive
conflict. This study addresses that gap by examining how conflict unfolds in daily life, focusing on natural
escalation within individual episodes as well as broader day-to-day conflict patterns over two months. Findings
will identify the features that contribute to maladaptive conflict, shedding light on when and how conflict
becomes harmful. By identifying these distinguishing features, this research will inform the development of
targeted interventions aimed at supporting healthier family relationships.
This project addresses two complementary aims, offering both detailed and broad perspectives on parent-child
conflict. The first aim takes a “zoomed-in” approach, examining naturally occurring conflict episodes captured
through at-home audio recordings. It focuses on specific features such as baseline intensity and the trajectory
of escalation, and how these dynamics are linked to same-day and next-day changes in child mood and parent-
child interactions. The second aim takes a “zoomed-out” view, using ecological momentary assessment surveys
to track daily patterns of conflict intensity, frequency, and duration over a two-month period. This broader
approach will examine how families’ overall conflict patterns relate to child mental health symptoms and
parent-child relationship quality. By integrating these two levels of analysis, the project will provide a more
complete picture of how parent-child conflict unfolds in everyday life—offering valuable insights to guide
interventions that strengthen family relationships and promote child well-being.

Public health relevance
PROJECT NARRATIVE Parent-child conflict is a common part of daily family life, yet a more precise understanding is needed of the core features—such as intensity, frequency, duration, escalation, and resolution—that differentiate maladaptive conflicts, which contribute to adverse outcomes, from adaptive ones, which support communication and growth. This training grant will address this gap by leveraging real-time smartphone audio recordings and daily surveys to capture the natural progression of parent-child conflicts, yielding both moment-to-moment insights and broader family-level patterns. By clarifying how conflict dynamics shape child and family well- being, this research will establish a foundational evidence base to identify specific conflict behaviors to target, enabling more precise and effective intervention strategies that promote healthier interactions.